Unraveling the neural mechanism underlying context-dependent decision making

PROJECT SUMMARY
Humans live in a complex and dynamic environment. In our daily lives, many decisions depend on contextual
information. For example, when drivers enter a two-way street in the US, they will stay on the right side of the
road. Once they travel to the UK (a different context), they will have to adjust their actions and drive on the left
side to follow local traffic rules. This capacity for flexible decision making is thought to be a critical part of cognitive
function and is compromised in psychiatric and neurological disorders, such as autism spectrum disorder (ASD),
attention deficit hyperactivity disorder, and obsessive-compulsive disorder (OCD). How does a healthy brain
process contextual information and flexibly modulate the behavioral response? How is this neural computation
altered in patients with cognitive inflexibility? Neuroimaging studies in humans have indicated that the frontal
lobe is responsible for this executive function; however, mechanistic studies in animal models have shown mixed
results. Our lab takes advantage of the rapidly developing genetic and imaging tools available in mouse models
to study the neural mechanism underlying context-dependent decision making. We have recently discovered
that the premotor cortex (anterior lateral motor cortex, ALM) encodes both contextual cues and behavioral
choices using an olfactory-guided delayed match to sample (DMS) task. More importantly, neural processing in
the ALM (but not orbitofrontal cortex) is required for animals to optimally perform this task. In this proposal, I aim
to unravel the neural mechanism and computation underlying flexible decision making at both the subcellular
and network levels.
I first aim to develop a new context-dependent olfactory decision (CDOD) task to address a potential confounder
in our previous work and establish a robust and simple behavioral paradigm to study flexible decision in mouse
models. Next, I will elucidate whether and how the context selective neurons in the ALM, including pyramidal
neurons and subtypes of interneurons, mediate the flexible response in choice neurons by using 2-photon
imaging, targeted 3D photostimulation, and computational modeling. I hypothesize that the context selective
neurons in the ALM mediate the functional state of the choice neurons through dendritic gating to regulate the
flexible behavioral response. Furthermore, I will test the causal role of context specific neurons in decisions using
large-scale 3D photoinhibition. Lastly, I aim to identify the upstream brain substrates that enable the processing
of context information in ALM.
Answering these questions will contribute to the core goal of NIMH by advancing our knowledge about the neural
mechanism behind flexible decision-making, which is altered in mental illnesses such as ASD and OCD. Using
the proposed experiments in the olfactory system as an entry point, I hope to provide insights into the
fundamental cognitive functions involving perception and decision-making.

Public health relevance
PROJECT NARRATIVE To navigate our complex and dynamic world, humans must use information obtained from past experiences and environmental/social cues to guide their decisions. This critical cognitive function is compromised in patients with autism spectrum disorders and obsessive-compulsive disorder. This study aims to advance our understanding of the neural basis of context-dependent, flexible decision making which may lead to the prevention and treatment of these mental illnesses.